ESCALATING MULTIPLE DOSE SAFETY AND TOLERANCE OF WR 6026 IN HIV PATIENTS

Doses of up to 90 mg of WR 6026 given once daily are acceptably safe and well tolerated. No serious or life-threatening toxicity has been observed.